DIETHYLDITHIOCARBAMATE IN HIV INFECTED PATIENT

Work has focused on identifying if Diethylthiocarbant changes (a) intracellular glutathiene levels and (b) the ability of peripheral blood mononuclear cells to withstand antioxidant stress in subjects with HIV-infection.